Short-Term Training to Increase Diversity in Health-Related Research

ABSTRACT
The overarching goal of the Summer Research Internship Program (SRIP) is to exploit the rich research
community at the University of Virginia (UVA) to expose underrepresented undergraduate and medical
students to the excitement, capabilities, rigors, and breadth of opportunities for careers in biomedical
research. From its inception, the major goals of this NHLBI-supported program have been (1) to expose
undergraduate students to the state-of-the-art in cardiovascular, pulmonary and hematological research;
(2) to familiarize the students with the opportunities that exist for careers in research; (3) to encourage and
facilitate them pursuing a career in research; and (4) to kindle and nurture a passion for doing research
that truly makes a difference and leaves a mark on mankind. This application seeks support to continue
this successful program, through which ten (10) undergraduate and/or post-baccalaureate students and
five (5) rising second-year medical students participate in the SRIP each year. The ten-week program has
three educational components. The first and most important is an immersive, hand-on research
experience mentored by of one of our 56 program faculty and focused in the mission areas of the NHLBI.
Second, the trainees participate in a weekly 1-hour workshop focused on developing and refining scientific
communication skills appropriate for various contexts and audiences. Finally, the trainees attend a
professional development luncheon series that provides instruction in successful admission to graduate
and medical school, panel discussions of career options led by current students, and opportunities to
interact with and learn from basic scientists, translational researchers and physician scientists. These
presentations are intertwined with practical experiences focused on positioning both the undergraduate
and medical student trainees for success at the next stages of their career. To date, more than 50% of the
undergraduate SRIP alumni have successfully made the transition in graduate and/or medical school.
Through strong mentorship, hands-on research, innovative educational initiatives, and exposure to a wide
range of research and clinical care experiences, trainees in the SRIP are uniquely prepared to pursue
advanced training with the ultimate goal of becoming members of a diverse biomedical workforce.
!

Public health relevance
NARRATIVE The landscape of biomedical research in the United States is changing, as are the composition and activities of the biomedical research workforce. With this evolution comes an increasing need to encourage talented young people from underrepresented groups to explore the changing landscape in cardiovascular, pulmonary and hematological research and pursue careers that will contribute to a better understanding of the factors that promote the diseases under investigation, the development of methodologies to predict and/or prevent disease progression, and the discovery of therapies that will help cure patients. The Summer Research Internship Program (SRIP) at the University of Virginia addresses this need by providing undergraduate and medical student trainees from underrepresented groups with an immersive research experience within a rich research community that boasts strong and diverse basic science, a world renowned Cardiovascular Research Center, and opportunities for exposure to the practice and challenges of providing clinical care to patients with cardiovascular, pulmonary and hematological diseases.